GLOBAL SCREENING ARRAY (BRENNAN) FOR NIDCR/NCI

NCI funded contract support for the NIH Center for Inherited Disease Research (CIDR). Contract tasks include providing high quality throughput genotyping, sequencing, and epigenetic services to eligible investigators.